Novel mechanisms of kidney inflammation and fibrosis

PROJECT SUMMARY
Chronic kidney disease (CKD) is a public health problem that afflicts more than 37 million Americans.
The current therapeutic options for this progressive disorder are limited; therefore, novel therapeutic strategies
are urgently needed. Common features of CKD are kidney inflammation and fibrosis. Inflammation often triggers
fibrosis, and fibrosis is the end result of chronic inflammatory reactions. Renal inflammation is characterized by
macrophage activation and proinflammatory molecule production. However, the molecular mechanisms
underlying macrophage activation are not fully understood. Therefore, the long-term objective of this proposal
is to understand the molecular mechanisms of macrophage activation so that effective strategies can be
developed for the treatment of CKD.
We have identified PU.1 as a critical factor in the regulation of kidney inflammation during the
development of CKD. Specifically, we have demonstrated that PU.1 is induced in the kidney in experimental
models of CKD and in human kidney with CKD and PU.1 is obligatory for macrophage activation and
inflammatory molecule production and development of CKD. Genetic deletion or pharmacological inhibition of
PU.1 prevents macrophage activation and inflammatory molecule production in macrophages in vitro, and
pharmacological inhibition of PU.1 suppresses macrophage activation, inflammatory molecule production, and
fibrosis development in the kidney with obstructive injury. Furthermore, the proinflammatory effect of PU.1
appears to be mediated by the NOD-like receptor family pyrin domain–containing 3 (NLRP3) inflammasome
pathway. In this application, we propose to examine and characterize the role of PU.1-NLRP3 pathway in
macrophage activation and polarization and proinflammatory and profibrotic molecule production to further
understand the molecular mechanisms of inflammation and development of kidney fibrosis. Our central
hypothesis is that PU.1 promotes NLRP3 expression and inflammasome activation in macrophages leading to
proinflammatory and profibrotic molecule expression and development of kidney fibrosis. To test this hypothesis,
we will pursue the following Specific Aims. Specific Aim 1 is to determine the role of PU.1 in macrophage
activation and polarization in vitro and in vivo. Specific Aim 2 is to dissect the molecular mechanisms by which
PU.1 promotes macrophage activation and polarization. Specific Aim 3 is to explore the therapeutic potential of
a selective PU.1 inhibitor for the treatment of CKD.
We plan to utilize molecular, genetic, and pharmacological approaches to examine the role of PU.1-
NLRP3 pathway in macrophage activation and polarization and development of kidney fibrosis. Results from
these studies will provide novel insights into the molecular mechanisms of kidney inflammation and could lead
to the development of novel therapeutic strategies for the treatment of CKD.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease is characterized by damage to kidney cells, accumulation of immune cells such as macrophages, and development of kidney fibrosis. We propose to study how PU.1 signaling pathway regulates macrophage activation and development of chronic kidney disease. Results from our study could provide novel insights into macrophage activation and development of chronic kidney disease and could lead to novel therapeutic strategies for chronic kidney disease.